Defining and Manipulating Epigenomic Regulators in Endogenous Systems

Our overall goal is to understand how mechanisms impacting the epigenetic regulation of gene expression contribute to cancer development and progression. As an initial effort, we have focused on the development of small molecules tools able to profile and perturb the activity of lysine acetyltransferases (KATs). These enzymes catalyze lysine acetylation, a widespread protein posttranslational modification involved in the regulation of gene expression, DNA repair, protein stability, and metabolism. To better understand the role of protein acetylation in cancer, we have taken a multi-pronged approach. 1. Characterization of novel KATs. First, we have developed a chemoproteomic method capable of globally profiling cellular KAT activities. Our initial studies lead to the identification of NAT10, an orphan acetyltransferase that is prevalent in cancer cell lines. Currently we are working with collaborators to characterize the biological activity of NAT10 and other orphan KAT enzymes, as well as their relevance to cancer cell growth and proliferation. 2. Identification of KAT inhibitors. Targeting the cellular acetylation machinery for anticancer treatment is an emerging therapeutic paradigm; however, KATs represent a relatively unexplored target relative to HDAC and bromodomains. We have developed a new microfluidic assay for the analysis of KAT activity. Currently we are working together with colleagues at the National Center for Advanced Translational Science (NCATS) to apply these assays to identify novel KAT inhibitors. Our pilot studies have identified several novel candidate KAT inhibitors, and follow-up studies are in progress in order to validate these hits, their mechanism of action, and biological activity. 3. Metabolic regulation of epigenetics. We have applied our chemoproteomic KAT probes to identify palmitoyl-CoA as a novel endogenous inhibitor of KAT activity. Palmitoyl-CoA is the most potent endogenous KAT inhibitor reported to date, and our initial biological studies suggest palmitoyl-CoA may mediate context-dependent metabolic interactions between fatty acid metabolism and epigenetic signaling. Future studies are aimed at elucidating this interaction, applying this knowledge to the discovery of novel drug synergies, and developing chemoproteomic approaches capable of providing further insights into metabolic regulation of epigenetic signaling. 4. Diagnostic detection of oncometabolites. Finally, in a collaborative effort we are developing new metabolic tracers for the imaging of cancers exhibiting epigenetic dysregulation due to metabolic mutations. Our goal is to apply simple chemical insights regarding the uptake and solubility of cell-permeating metabolites in order to improve the sensitivity of hyperpolarized 13C imaging agents. By focusing on technologies applicable to the study of these enzyme activities directly in living cells, our studies represent foundational steps towards the identification of novel mechanisms of epigenetic regulation, as well as the development of next-generation therapeutics and diagnostics for cancer treatment.